The 18th INTEREST Conference

Abstract. The most recent UNAIDS estimates of the global burden of HIV are that 39.0 million people are living
with HIV-1 infection worldwide, with 65.6% of them residing in sub-Saharan Africa. Despite an overall 38%
worldwide decline in newly acquired infections, we still faced a staggering number of 1.3 million new infection
and 630,000 deaths in 2022. A difference still exists between the east/southern and the west/central regions of
sub-Saharan Africa, with reductions in AIDS-related deaths in 2021 of 50% and 43% since 2010, respectively.
Clearly, much work remains in terms of training health care workers including local physicians and scientists in
the diagnosis, treatment, and management of individuals with HIV-1 infection; conducting implementation
science to determine the most cost-effective use of financial and human resources; and ensuring evidence-
informed public health policy and programming to reduce disparities in the AIDS response across Africa’s sub-
regions. Despite treatment likely having contributed to slowing HIV transmission, HIV prevention remains critical
to stem the tide of HIV. In fact, a second AIDS pandemic in the next 12 years is predicted due to 1) changing
demographics in Africa with increasing numbers of youth, 2) increasing transmitted viral drug resistance, and 3)
increased cost and limited availability of 2nd and 3rd line treatment regimens. These factors suggest that the total
number of people living with AIDS may increase by 2 million/year to reach a staggering 50 million worldwide by
2030.
Since 2007, 17 successful annual INTEREST Conferences, known as the ‘African CROI’, have brought
together scientists involved in HIV diagnosis and treatment, pathogenesis, and prevention research in resource-
limited settings in Africa to share pivotal findings, promote collaboration, and transfer experiences across several
fields and many continents. Planning and organization of the 2024 INTEREST Conference will be overseen by
the Amsterdam Institute of Global Health and Development. Dr. Kwasi Torpey (University of Ghana School of
Public Health/Amsterdam Institute for Global Health and Development) chairs INTEREST’s International
Conference Committee (ICC) and is the Scientific Chair of INTEREST. The organizers of the 2024 INTEREST
Conference will pursue the following objectives to target the early-stage African investigators who will be
provided the necessary travel support by this proposal:
1) To provide cutting-edge knowledge in the fields of diagnosis and treatment, pathogenesis and
prevention of HIV-1 for adults, adolescents and children living with HIV in Africa, in order to contribute
to achieving the 95-95-95 viral suppression goal and to preventing a second great HIV pandemic.
2) To provide career development opportunities to early-stage investigators who represent the
potential future scientific leadership for health care and research on the African continent and foster
new research interactions between them and leading investigators in the field.

Public health relevance
Project Narrative. Currents efforts are ramping up to control local HIV epidemics in Africa by providing effective treatment and prevention strategies for people living with HIV-1 infection. The 2024 INTEREST Conference will focus on the scientific training and capacity building of young African health care providers and basic science investigators to achieve the UNAIDS 95-95-95 target for 2030 by implementing and evaluating evidence- based: 1) early HIV-1 diagnosis in population at risk of infection, 2) effective and cost-effective antiretroviral treatment to achieve virus suppression, and 3) tailored prevention strategies. Moreover, the three-day INTEREST conference, which profiles state-of-the-art science, will support the career development of young African clinicians and scientists by: 1) fostering local and international scientific exchange; 2) providing opportunities to present their results; 3) facilitating their close interaction with scientific peers and invited international experts to explore career choices and opportunities for scientific collaboration; and 4) attending events dedicated to scientific writing of abstracts and grant proposal.